Molecular Pathogenesis of the Hamartoma Syndromes

Overall - Project Summary/Abstract
Please see each project/core for individual Project Summary/Abstract

Public health relevance
Overall: Narrative The overall goal of this program project application is to find treatments for the hamartoma syndromes, and the common cancers in which these same genes (TSC1, TSC2, LKB1, PTEN) are involved. Please see individual Projects and the Core for each Project Narrative.